CORE--MICROARRAY

The worldwide genomics effort is poised to yield insights into numerous diseases, including cancer. New technologies are being implemented to more effectively exploit these massive amounts of genetic data that will undoubtedly increase several fold in the near future. To this end, microarrays have emerged as a powerful tool for simultaneous examination of thousands of genetic measurements. It is anticipated that microarray technology will play a significant role in cancer research to characterize underlying mechanisms, develop molecular diagnostics/prognostics, and eventually facilitate cancer therapeutic decision-making. The Microarray Shared Resource was developed to provide Center investigators with this technology that heretofore has been available on a very limited basis in academia. Current resources include an Affymetrix GeneChip system with which assays for RNA expression; resequencing of p53, HIV protease/reverse transcriptase, and cytochrome p450; or determination of single nucleotide polymorphisms can be performed using specialized high density oligonucleotide-based GeneChip arrays. To complement the GeneChip approach for RNA expression assays, the Resource has also partnered with the UCSD BIOGEM Lab to produce and assay spotted glass-slide microarrays. In addition to performing microarray assays, the Resource provides expertise in experimental design microarrays. In addition, an Array Science Journal Club and Workshops has been implemented to educate and train investigators in this rapidly evolving field. This Resource is instrumental to investigators conducting either or both basic and clinical cancer research in all of the Center Programs. It also enables the development of intra- and inter-Programmatic interactions throughout the Center and encourage others, not currently performing cancer research to become involved in Center activities.